Understanding the effects of motor learning in wild-type and Mecp2-deficient mice

Project Summary
Observers of children or young animals will notice how much learning about the world depends on being
able to move within it. Indeed, studies in humans and other primates have shown that the motor cortex (M1) is
involved in working memory, empathy, and language. Could motor dysfunction contribute to the various
cognitive and affective deficits that occur in neurodevelopmental disorders (NDD)? Conversely, could
improving motor function improve other aspects of NDD phenotypes? Recent work from my lab provides
evidence that this may be the case.
We have been studying Rett Syndrome (RTT), which is caused by loss-of-function mutations in the X-
linked gene methyl CpG-binding protein 2 (MECP2) and is a leading monogenetic cause of NDD, affecting 1 in
10,000 live female births. The phenotype is striking for its postnatal onset: affected girls appear to develop
normally and reach the appropriate milestones for the first year or two of life before they regress, losing most
acquired skills and developing motor, cognitive, and social abnormalities. Both male and female Mecp2-
deficient mice replicate this natural history, and the delayed onset strongly suggests that although MeCP2 is
expressed from early development, it has additional, as-yet unclear functions in maintaining mature neurons
and synaptic connections. We therefore set out to ask two questions: 1) how does MeCP2 deficiency affect the
process of learning at the motor circuit level, and 2) would motor learning exert beneficial effects beyond the
particular skill learned? We used calcium two-photon imaging to simultaneously record excitatory activity in
layers 2/3 and 5a while 8-week old wild type and null male mice learned to adapt to changing speeds on a
computerized running wheel over two weeks of training. We found that a subgroup of M1 neurons in layers 2/3
and 5a strengthen their functional connectivity while the rest of the population decreases functional
connectivity, likely to maintain flexibility for learning new skills. Loss of MeCP2 attenuates but does not
abolish this reorganization: although cross-layer connectivity was much lower in the null mice, and the
functional connections between neuronal pairs in the null M1 circuit last half as long as those in WT, the null
M1 circuit retains enough plasticity to support motor skill learning. Moreover, trained null mice showed less
anxiety-like behavior and lived ~20% longer than untrained mice (manuscript under re-review). This is all the
more remarkable given that the entire brain is disrupted by loss of MeCP2. This work laid the foundation for
the current proposal, which seeks to understand the contributions of cortical inputs and inhibitory neurons to
L2/3 plasticity during learning, determine the effects of motor learning on M1 in female Mecp2 heterozygous
mice, and shed light on how 'normal' the M1 circuit actually is in presymptomatic RTT mice.

Public health relevance
PROJECT NARRATIVE Loss of function mutations in MeCP2 cause Rett syndrome (RTT), a leading monogenetic neurodevelopmental disorder with a hallmark of progressive loss of acquired motor and cognitive skills. Recent work in our lab has found that Mecp2-null mice are still capable of developing motor skills, and that this motor learning benefits the mice in other domains. This proposal will deepen our understanding of motor cortical function at the circuit level in both mutant and wild-type animals.